14th International Conference on the Chemistry and Biology of Mineralized Tissues (ICCBMT)

ABSTRACT
The purpose of this application is to obtain partial support for the upcoming 14th International
Conference on the Chemistry and Biology of Mineralized Tissues (13th ICCBMT) on October 22-27,
2023 at Hotel De Bilderberg in Oosterbeek, The Netherlands. All the requested funds are targeted to
Travel Awards supporting the attendance of graduate students and postdoctoral fellows from the United
States. This meeting, as a part of a longstanding conference series, is a forum to share the newest
advances in research on the structure, function, and interactions of the mineral, extracellular matrix,
and cellular components in teeth, bone, cartilage, shells, and other biomineralized structures, and on
soft tissues that undergo pathologic mineralization. The meeting likewise encourages communication
and collaboration among attendees from both clinical and basic science disciplines. Specific aims of
the 14 ICCBMT are to: 1. Assemble a multidisciplinary and diverse group of national and international
scientists with a common interest in biomineralization and its related dysregulations; 2. Disseminate
state-of-the-art and novel information about the structure, function and interactions of the mineral,
matrix and cellular components in vertebrate and invertebrate tissues; 3. Provide an environment that
foster meaningful interactions and collaborations among investigators across diverse scientific
disciplines; 4. Support participation and mentoring of young investigators and trainees though Travel
Awards and forums, providing these individuals a platform to present their work and interact with senior
investigators; 5. Encourage and support participation of women, minorities, and persons with disabilities
while ensuring high quality scientific program; and 6. Communicate the knowledge presented through
a published ICCBMT meeting proceedings in a peer-reviewed journal, broadening the national and
global accessibility of critical findings to other scientists and clinicians. These outcomes will promote
the basic mission of the NIAMS and NIDCR by providing new knowledge to improve the skeletal and
oral health of our nation through high-quality novel research, by facilitating interactions and
collaborations among scientists across multiple fields related to mineralized tissues, by providing
networking and training to early-stage scientists and students in the field, and by broad open
dissemination of the meeting’s findings through a peer-review process.

Public health relevance
NARRATIVE The purpose of this application is to obtain partial support for the 14th International Conference on the Chemistry and Biology of Mineralized Tissues (13th ICCBMT) to be held on October 22-27, 2023 at Hotel De Bilderberg in Oosterbeek, The Netherlands. This Conference will disseminate the newest research findings on biomineralization in dental and skeletal tissues and tissues affected by ectopic mineralization, while facilitating exchange of ideas and collaboration among clinicians and scientists and between early-career investigators and experts in the field. The conference is highly relevant to public health, as it addresses mechanisms of mineralization disorders and potential therapeutic approaches, including novel biomaterials and strategies for regeneration and repair of mineralized tissues.